San Antonio Nathan Shock Center of Excellence in the Biology of Aging

Abstract
This administrative supplement seeks funds to purchase a newly developed dual energy X-ray absorptiometry
(DEXA) system that will enable UTHSCSA’s Nathan Shock Center (NSC) to offer state-of-the-art technology for
in vivo and ex vivo assessment of body composition and bone mineral density of aging animals. Currently, our
NSC Aging Animal Models and Longevity Assessment Core is responsible for breeding and maintaining several
thousand aging mice, a naked mole rat colony, and aging common marmosets for investigators in San Antonio
and nationwide. This Core in conjunction with the Integrated Physiology of Aging Core provides investigators
with healthspan measures ranging from lipidomics, single cell transcriptomics, muscle function, frailty, cognition
and behavior to pathophysiology. The DEXA system will fill a critical gap in these age-related phenotyping
services missing since an earlier outdated, highly used system had to be abandoned over a decade ago,
due to the manufacturer stopping production and no longer providing repair service. The addition of in
vivo DEXA assessment of body composition (lean and fat mass) and bone mineral density and content will thus
provide critical outcome measures that will benefit many investigators using NSC Core services to study topics
such as the effects of diet and nutrition, food restriction, and drug and genetic interventions on aging processes.
The NSC at San Antonio has been part of the Barshop Institute for the Study of Aging for over 27 years, providing
specialized services and consultation for aging research to many investigators seeking to understand and
develop therapeutic interventions to ameliorate the aging process. During this time, the NSC Cores have
undergone a continuous expansion to provide ever more comprehensive phenotyping of aging-sensitive traits.
Far superior to the earlier system, the newly developed DEXA system is a fully shielded system with a much
higher resolution (100 µm µm pixel size @ 1.2x and 31 µm @ 4x, along with a wide scan area, allowing for
animals weighing from 0-500 grams (mice to marmosets). Furthermore, it can either scan the selected region of
interest or ex vivo samples (e.g., excised bones, organs), at a higher resolution. It is well suited for longitudinal
aging studies as the radiation dose is minimal, (0.66mGy per scan). Therefore, the accumulation of multiple
imaging timepoints will have minimal effects on animals during each imaging session, and are unlikely to affect
study outcomes. Scans only take 25 seconds to complete, allowing for high throughput of animals. It will be
installed in one of the rooms dedicated to measuring healthspan traits in the Aging Animal Core Facility in the
Barshop Institute.
This request for a DEXA system conforms to the stated purpose of supporting and enhancing shared resources
for categorical research by many investigators from different disciplines. The DEXA system will be an added
benefit that will provide more comprehensive data for aging/longevity and various interventional studies.

Public health relevance
Project Narrative This is a request for funds to purchase a state-of-the-art dual energy X-ray absorptiometry (DEXA) system to fill a gap in healthspan measurements offered by the San Antonio Nathan Shock Center. The DEXA system will be an added benefit that will provide more comprehensive data for aging/longevity and interventional studies.